Administrative Supplement - Desinging peptide macrocycles to selectively inhibit BET proteins: Martinez Noa, Yisel

BET proteins are involved in mul3ple diseases associated with the misregula3on of immune
response genes. Through the parent grant we are characterizing the ET domain for its poten3al
as a drug target and iden3fying the origin of selec3vity across homologous ET domains. Within
this supplement we take a further step and propose the design and characteriza3on of pep3de
macrocycles as poten3al drugs using an array of computa3onal chemistry tools, which we will
later characterize with our experimental collaborators.

Public health relevance
This supplement will allow the development of peptide macrocycles as drug candidates targeting BET proteins involved in regulating our innate immune response. BET proteins are also the target of multiple virus and their misregulation leads to different types of cancer. Our novel macrocycle strategy will target a new domain in BET proteins leading to lower side effects and toxicity than previous drug strategies.